Rhodopsin-initiated signal transduction and behavior in Drosophila and Aedes

Abstract
The goal of the proposed research is to decipher a diversity of unexplored behavioral roles for rhodopsins in
Drosophila melanogaster, and in the major disease vector, Aedes aegypti. The proposed studies build on our
recent discovery that a fly rhodopsin (Rh7) acts as a light sensor in a small set of neurons in the brain, where it
contributes to circadian photoentrainment. This represents the first function for a rhodopsin in the central brain,
despite decades-old reports that rhodopsins are expressed in the brains of many animals, including humans.
We propose to bring to bear a wide set of tools to reveal the rhodopsins and signaling proteins employed in the
fly brain and eye for circadian photoentrainment and for sleep. We will then leverage our extensive background
in flies and our recent expansion into mosquitoes to reveal the mosquito rhodopsins required for circadian
photoentrainment and for detecting humans under different light conditions. This goal is important, since
mosquitoes rely heavily on vision to identify humans. Yet, there are no molecular genetic studies focusing on
vision or rhodopsins in any insect vector. The project’s success will be made possible by our development and
application of an extensive suite of in vivo approaches including electrophysiology, behavioral assays, cell
biology, molecular genetic approaches, and expertise in creating gene knockouts in Aedes. We propose to
capitalize on a transformative technical innovation we have developed to accelerate molecular genetics in
mosquitoes. Aim 1 will test the hypothesis that Rh7 in the fly brain functions in circadian photoentrainment
through a signaling cascade distinct from the one used in the compound eye. The experiments will also test the
idea that Rh7 confers greater light sensitivity to pacemaker neurons than is possible through Cryptochrome,
the other light sensor in the brain. Aim 2 focuses on illuminating the roles of different rhodopsins in the
Drosophila eye and brain on sleep. We will address the concept that two rhodopsins in a small subset of
photoreceptor cells in the compound eye are required for normal nighttime sleep, while Rh7 in the brain affects
daytime sleep. In Aim 3, we will decipher roles for rhodopsins in Aedes that are required for increased visual
attraction to humans, following exposure to CO2. We will clarify which rhodopsins are most important for host
recognition at different intensities of light. Finally, we will unravel roles for two rhodopsins expressed in the
Aedes brain. In summary, the proposed project will deepen our understanding of visual and non-visual
rhodopsins that function in circadian photoentrainment and sleep. These are important goals, since our
understanding of the mechanisms underlying sleep is rudimentary, and many diseases are exacerbated by
impairments in this evolutionarily conserved behavior. Finally, given the importance of mosquito vision for
identifying humans, we propose that unraveling the rhodopsins that contribute to human recognition offers to
lead to creative CRISPR/Cas9-based approaches to control insect vectors and reduce disease.

Public health relevance
Project narrative One of the goals of this project is to define the impacts of different light receptors, called rhodopsins, on setting circadian rhythms and for normal sleep patterns. The insights gleaned from this work have potential to provide insights into diseases that are exacerbated by impairments in circadian rhythms and sleep. A second goal of this project is to define the rhodopsins in mosquitoes that are most important for recognition of humans, with the long-term goal of devising new strategies to interfere with the attraction of mosquitoes to humans and reduce insect borne disease.